EFFECT OF TACROLIMUS ON ENDOTHELIN 1 SECRETION IN LIVER TRANSPLANT PATIENT

This study will characterize a time-dependent disposition of a new immunosuppressive agent, Tacrolimus, and its effect on endothelin-1 secretion in stable organ transplant patients.